Community Outreach and Ethics Core

ABSTRACT The mission of the Community Outreach and Ethics Core (COEC) is to support the Center in achieving its overarching mission of Building Capacity and Collaborations, inspiring Creativity, and facilitating Communication in environmental health sciences (EHS) research. To do this, the COEC plays a central role in connecting Center investigators, community partners, and other stakeholders in productive EHS-focused dialogue and activities. Our COEC has developed a strong presence in the region and has a reputation as a trusted partner of stakeholders who include educators, tribal nations, public health professionals, government agencies, non-profit organizations, and academia. One of COEC's areas of strength is our strong commitment and expertise to address the ethical, legal, and social implications (ELSI) that relate to Center research. Our aims for the next funding cycle build on our strengths and expertise, support the mission of the Center, promote innovative research, engage stakeholders, and foster the development of the next generation of EHS innovation and networked researchers focused on exposures, diseases, genomics, and the environment. Some proposals in this application build on our ongoing programs that have been in place through several grant cycles and have evolved in collaboration with stakeholders as the COEC has established long-term and meaningful community partnerships. These include The Academy for Teaching About Health and Environmental Associations (ATHENA); Native Tradition, Environment And Community Health (TEACH); Public Health Café; our partnerships with the Duwamish River Cleanup Coalition and Collaborative for Health & Environment and dissemination of our work on social media through blogs, Twitter, Facebook, and YouTube. New initiatives include cultivating potential new partnerships with participants in the UW Tribal Leadership Summit and the National Conference of State Legislators. In our Native TEACH program, we plan to introduce a Scientific Workshop, career training for Native students, jointly funded collaborations between Center and Native researchers, and to re-establish the inter-COEC Tribal Collaborative Working Group. In addition to our outreach efforts, we will reach inward to our members through monthly Breakfast Club gatherings where research is shared and collaboration encouraged, and offer communications training for members and trainees, including Lightning Talk events and a graduate class in outreach and engagement. COEC is an integrating element in the Center, translating and disseminating Center research to stakeholders and the community, and connecting CRTs and Center members with each other and with our community partners. The COEC will build on its previous efforts and successes as well as expand in new directions as we enter the new grant cycle and the next phase of EHS research.